EFFECT OF LOWERING CHOLESTEROL ON THROMBOTIC MARKERS

The specific aim of this protocol is to demonstrate that lowering cholesterol levels in patients with or without coronary artery disease (CAD) treated with an HMG-CoA reductase inhibitor leads to reduction in the blood shear rate and induction of a less thrombotic and/or more fibrinolytic state.